RFA-CE-23-008, Development of a Mental health Outcomes Screening Tool (MOST) after mild TBI in adolescents: The MOST-mTBI study

0S5S;B214:2D4233:314:54415F58;22965A29I/4849@49D/436BB8F/14N6;BC251T41;4:14N3:@UD1/3C124A;84/46I261PC235/!@/6@044312P@9"EFB/6#4/@D82362199@399BB36B:/5//22V9$3GFB%&H/4:'98I2/%(J/V%)Q1F53*B6/1'497K2)48L/+4M,/P.S;2/4C/D0:612N/273;@42813:5F:@562427/3:5/819;N9//N;@2@43011OO/://S030;610422/<1:@P=0P>15F?19@?01993/Q614;15R/@2209F31;@/:90//0:W1P645Y/5/25Z@@3[3+D:21)@;2\0%C4]/1+3@B,20/633194B/1/53
S;20PBFC4////4S2PS@29:3;3/B4/23:@/P9;/3B@2F//;932@52CB53;9/3:34BBP2Q;1:9:R3:/B:/S1PSV43:B;4F///>E/V/0d9F5P1285/30/3;91/12:A:2@//33C3;153CC2/D2;0C45P3/P/P3A;4P//64P2:9;7;Q:@6S8FR71P4@2S28S6?2:3;4790F/;;;:8I29395/125^P2_:1B@45S///`/9:/0@:HPJ/3J6:13/9Q319T31@P@B_1@3N12@561:e?97I3F/9B/1080@/aI/5P32SB9^F@222/00:a331B3@SV4;c/N4F0/92/;J:0@AF1/J53231/S33@12:9U2933:331?5AB1//19//@1@@F3410251::5202/U93;1920@9C;/12523C:;5:5053V1;//20F4@A@/:1/304@:/293;I1/0:CS2DP:F1N;@5://5N124@01N2@2N/30>@/@@1>00052Tb2;>DJ33F4L/143J2BDP9;/5/42:;@4/P:32@IP91J@N;B@;
21/20J2J9SC@24030/22113@B:39/;;A39BPDN@14//99?//:F@125@/9/3;::22/13J355PS:N94DP9///;DIP/I6@@54222AU/S74333@:@:2F1@48530Q;091B31/3J05/9R4;C1@:;322/10C3/4;FBS3P:;4/@15N:14@29@/;9111B2/932@1JF:S/309NBPS4S4:0/;/2/4a22/F;SI@5@4S@39N;20/3/304011@4@A0bA4/3;P;10/11P1A@:;/4:1531@^J9;J2@3/;511:FS5524I@;a@:9B@^N31431@;2?@;:131c@3:29a/3;F9/T//D4@VJ90;@DN1F951CA:@//4@52;22FBN2/2;9P394/14U9113/@0;;@22S5:S2C@139@2341;//3PAB1N/0;:B@4//1/CC/;:;C32VB04F@3040;B53F/:32Q;2/P3023;i33C92/3;;V4/B52::;/FCN/41Q49N4219;/23J;R/;@19P51@9@S331@1P29B2/JN49/393C4011B1:3;2A4:9gF/9/1/53//:d0?/4VFU@1f14/A2F@:/32/22/@/2PFN@3CA09931:2I14;B0@/2;//?V@/291F0;S@1F9NJSS41;S2@93;1:C;41:0@N323;B3/F23;/N1c1S5@3;3C@@2@2j430CU4;13;h3A/1;/5/BA3:/;4992D/2/93/413@/5C0>D5:C200S;h1S3334452214;9h:/0;//33U;3h;22@::;/9g4315/C52/:FB?T/@P02:;2B3C@3B1;92/:@/0J;329:5/0N/2/@/330:943/;3?2NB5:5B@4;T49:/:2:^4?;@45Q;@;:2/2F99R33:5C159:S:B@/3111/;/C:;/P1012504/4/Q?02NC:45Sc12R9//4;24d3::S050B;9S3/f;4/;/N;S>L0N@/9@A4/>j4134;5;;11:h1:T0PA22@:>5U//593L/61445B;@2:27DCI35@2/:83/0@B21@I0/4:
::P5_5/;/`;3P3@41H@1P3@2N6N9:FTBQP@3;/1k36;2D'979T3\?2B%8)2@P:%:0l///*V;0@\F+?3S2/m322992n14B@/3o/15\C2)C/1S;9n3/2B9p90;3;:?J+/42qD1V5@,FUN46//BCP:9421/;:6/2P7:4:5385F:B?403I/2DD2/U2@@C/19019B9@9;:;N0J9201A13@/;5/N4;44:1:93/Q1/;526@240B99D251N:3;1220@SS/::4;@1;F0E3F://1C41541@5523N/23J13;121@1;@9S9@@:SS;24;CA;;@32/2403@511AP33B14/2//S9:P299D/I3PP/33;34B//20;@@@/033:2A:C;3;/I1C;4913;P@@BS5;29P:2F5/@042;01@2@:23NA:NN2?A/49112/P0N42210/;33//2@F:33:233;BI54C/12:U4/Q

Public health relevance
08(""(124"3,4&56'''08'9'1!1)'''29*69!!''+77,4!!"!!7"'!"-,'.2!/(*0"!"((!0"4"!!0""0"!(!0"0"4!!8!11""9#*,$!%,544'"!"'+0'4!+2"!42(3';'!!","4(!"!0!46"'"!!04"!(!"6('"0"'!"(4!!!'!4!4&6"!"2&!"!"+(4+'0!0"("%'!%0:'""5&'%005.,"!'"46&!!(("+7!"+",0+'"